Bridges to the Future

DESCRIPTION (provided by applicant): San Francisco State University (SFSU), the University of California, Davis (UCD) and the University of California, San Francisco (UCSF) called PhD Partners hereafter, have developed a cooperative graduate program to increase the number of underrepresented minorities (URM) that pursue biomedical research careers. Our program goals are to provide URM students with a quality and focused master's degree education at SFSU that prepares them to be competitive for acceptance and successful in top-ranked biomedical science doctoral programs. The objectives are to ensure that the master's degree Bridge students: 1) pursue a critical and exhaustive examination of discipline subject matter graduate courses that lead to an MA/MS degree in a biomedical science (i.e. biology, biochemistry or chemistry) in two-three years; 2) achieve competitive scores on their GRE exams to ensure acceptance into a high quality biomedical PhD programs; 3) receive intense advising and the support necessary to become confident and successful graduate students; 4) participate in significant research experiences and acquire the skills required to communicate the results of those experiences in the form of theses, presentations at national scientific conferences and in peer-reviewed journals; 5) develop strong skills in science writing, and 6) receive continual exposure to successful minority scientists to build the confidence they will need to become outstanding scientists. These objectives will be successfully met through the combination of an excellent curriculum, close and careful advising, workshops designed to provide the students with a well-rounded and in-depth knowledge of all aspects of biomedical sciences, and a nurturing and productive research experience with Bridge mentors. These activities will prepare URM students for entry into high quality PhD degree programs, and/or biomedical research careers. Forty-three of our past MS/PhD Bridge to the Doctorate masters' students are currently enrolled in or have completed PhD programs at UC Partner campuses or other outstanding doctoral institutions. Five MS/PhD Bridge students who entered PhD programs withdrew for various reasons. Thus, 89.6% (43/48) of SFSU Bridge students have persisted in pursuit of a doctoral degree. Twenty-one have completed doctoral programs (17 PhD, 3 PharmD and 1 DVM). All 23 Bridge students since 2001 have entered competitive PhD programs. In addition to the students already in PhD programs, four of the current MS candidates in the Bridge program applied in 2007 for admission into PhD programs for fall 2008 admission and four will continue a second year. The SFSU/UC MS/PhD Bridge Collaborative Doctoral Program prepares master's graduates who continue into biomedical PhD degree programs in route to careers as research scientists. The partnership between the Minority Serving Master's I institution and two pre-eminent PhD granting institutions addresses workforce needs prepare researchers prepared to address health disparity issues.